10th International Conference on Tularemia

SUMMARY/ABSTRACT
This proposal seeks support for the 10th International Conference on Tularemia, which will be held from
September 25 – 28, 2023, in Grenoble, France. Tularemia is a rapidly progressive and potentially fatal
zoonosis of humans caused by the intracellular bacterial pathogen, Francisella tularensis. Because of its low
infectious dose and lethality when inhaled, F. tularensis was developed as a bioweapon, and remains a
potential bioterrorist agent. Research and understanding of tularemia pathogenesis, diagnosis, treatment, and
prevention have been significantly advanced by the International Conferences on Tularemia. Attendance and
impact of this meeting has grown steadily in subsequent years. This conference is a unique venue that brings
together scientists and interested parties from the U.S., Canada, Scandinavia, Europe, the Middle East, and
Japan. CBER/FDA has an ongoing commitment to facilitating development of medical countermeasures for
bioterrorism and emerging infectious diseases. Advancing development of medical countermeasures is an
explicit goal of this meeting. Senior scientists, clinicians, and trainees at all levels attend; attendees with
knowledge and interests outside the Francisella community also bring perspective and instructive
comparisons. The conference is designed to provide an environment that fosters collaboration and a free
exchange of ideas. Highlights from past meetings include announcing the discoveries of the Francisella
pathogenicity island (FPI); the Type VI secretion system encoded by the FPI; development of new animal
models; detailed genomic and proteomic characterizations that inform epidemiology of disease and
development of new therapeutic options; and identification of immune evasion strategies of the bacterium that
advance vaccine development. The 2023 conference will include a keynote address as well as six plenary
sessions, poster previews (flash talks) and three poster sessions, and additional opportunities for networking
during shared meals and social activities. The six plenary sessions will highlight the latest advances in
diagnosis and treatment of tularemia, vaccine development, host responses to infection, epidemiology and
bacterial ecology, bacterial physiology and gene regulation, and pathogenesis and cell biology. Each plenary
session will be chaired by scientists who are recognized leaders in the field. Over 85% of speakers will be
selected based on the merit of submitted abstracts. To achieve these goals, we seek support for meeting
logistics that will allow dissemination of research findings as well as professional development of attendees.
Specifically, we request support for rental of presentation equipment (audiovisual services and poster boards),
conference management and web site development, and travel support for attendees with financial and
educational needs.

Public health relevance
NARRATIVE The human disease tularemia is caused by Francisella tularensis, an intracellular bacterium that is found throughout the northern hemisphere and is a potential weapon of bioterrorism. The 10th International Conference on Tularemia will bring together scientists from all parts of the world and from all career levels in a collegial forum to discuss the latest Francisella-related research findings, to share data and reagents, to forge new partnerships, and to advance the development of new therapies, diagnostics, and vaccines. This proposal is therefore directly relevant to FDA’s mission to facilitate the development of countermeasures for bioterrorism agents and emerging infectious diseases.